COMPREHENSIVE COMMUNICATION SERVICES FOR NCI/DCCPS

The goal for this project is to maximize the NCI’s ability to facilitate significant achievements in cancer control and population sciences through strategic communication. DCCPS' Communication activities cut across all its programs with a goal of greater integration and enhancement of cross-cutting scientific areas, including implementation science, cancer survivorship, and health disparities.